GENES AND HIGH BP

Our Network proposes to carry out five specific aims to localize and characterize the genetic determinants of high BP. Aim I will use robust sibling pair linkage methods in 500 hypertensive sibling pairs in each racial group (a total of 1,500 sibling pairs) to localize genes influencing interindividual differences in the occurrence of Essential Hypertension. Aims 2 and 3 will take advantage of previously collected BP and intermediate predictor trait data from 1,488 normotensive sibling pairs from the Rochester Family Heart Study to localize genes contributing to Essential Hypertension. The proposed linkage analyses (Aims 1-3) will use both an extensive array of candidate genes and a large number of anonymous markers throughout the genome. Aim 4 will use multiple diallelic sequence polymorphisms and cladistic analyses within a linked gene to identify haplotypes for further DNA sequencing in order to identity ca date functional DNA sequence variation contributing to interindividual differences in BP levels and Essential Hypertension status. Aim 5 will evaluate the ability of candidate functional DNA sequence variation to predict Essential Hypertension status in three racial groups.